Biopsychosocial determinants of pediatric-onset chronic musculoskeletal pain

Abstract
Pediatric-onset chronic musculoskeletal pain disorders are common, but the mechanisms underlying their
pathophysiology are poorly understood. Current best practices in pediatric pain management focus on
symptom management and restoration of function. Absent a more mechanistic understanding of the drivers of
pediatric chronic pain and potential sub-types of chronic pain based on underlying pathophysiology (as
opposed to phenotypic classifications), pain providers are unable to target treatments to the root causes of
patients’ symptoms. There is no cure for pediatric-onset chronic pain, and many children and adolescents
continue to have pain in adulthood, highlighting the need for greater research into the development of novel
treatment strategies. At Cincinnati Children’s Hospital Medical Center, we have a large and well-established
multidisciplinary team of investigators who are already working to unravel the complex biopsychosocial
contributors to chronic musculoskeletal (MSK) pain in children. Our multiple ongoing registries and cohorts
have more than 2400 patients with pediatric-onset primary MSK pain disorders, pediatric rheumatic diseases,
and surgical interventions for whom we have rich medical history, pain-related and psychosocial data. The
proposed research would leverage these existing registries and cohorts to enroll a heterogeneous sample of
N=600 adolescents and young adults (ages 16-26); N= 400 with primary chronic MSK pain, or chronic MSK
pain secondary to rheumatic disease or major MSK surgery, and N=200 with a rheumatic disease or history of
major MSK surgery, but no chronic pain. Using a mixed retrospective-prospective cohort study design, we first
propose to combine and harmonize retrospective data from patients’ past clinical registry and research
records. We then will acquire prospective data regarding pain characteristics, quantitative sensory testing and
cytokine profiling and apply a model-based unsupervised clustering analytic approach to define mechanistically
distinct chronic MSK pain subgroups. Further, we will use serum samples from patients to conduct in vitro
experiments to identify neuro-immune signaling pathways impacting sensory transduction using an innovative
induced Pluripotent Stem Cell (iPSC) model. This mechanistic examination will be further augmented by
analysis of how psychosocial, behavioral and lifestyle factors mediate pain-related outcomes among
participants. In pursuing an analysis of patients that extends from the level of community characteristics to
single-cell assays, this research will result in the construction of a robust biopsychosocial model in which
patients across multiple pain sub-groups may be classified according to genetic and cellular mechanisms as
well as psychological, behavioral, and social features promoting risk and resilience. Through collaboration
across disciplines along with patient advisory partners, this study will reveal mechanistically driven treatment
targets for future therapeutic trials as well as novel insights into the relationship between painful MSK
conditions of childhood and the biopsychosocial factors that contribute to patient outcomes.

Public health relevance
Project Narrative This study will combine historical clinical and research data on children diagnosed with various painful musculoskeletal conditions with new data collected in later adolescence or young adulthood to study different neuroimmune mechanisms that may affect pain processing in a way that might cause chronic pain. We will also study psychosocial influences on chronic pain in young people. Results are expected to help us identify future targets for new therapies, or ways to prevent chronic pain from becoming a lifelong problem.